Mouse Paint: A massively combinatorial approach for illuminating tumor heterogeneity in True Color

ABSTRACT
Hundreds to thousands of malignant epithelial clones with unique genetic compositions and fitness potentials
are present in lethal cancers. Each clone competes against one another and also against a hostile immune
microenvironment. Remarkable selective forces establish reservoirs of therapeutically resistant tumor cells and
lethal metastases. Mechanistically mapping the evolution of tumor heterogeneity is the next great challenge in
cancer research. Genomics approaches have been developed for digitizing heterogeneity in tumors and
inferring lineage trajectories. However, gold-standard spatial information relied upon by pathologists for
centuries is lost in these techniques and the inferred lineage relationships must still be proven experimentally.
For almost three decades, genetically encodable protein tags have been invaluable for lineage tracing cell-fate
in vivo. The discovery of green fluorescent protein (GFP) added the benefit of fluorescence microscopy.
Spectrally resolvable GFP derivatives further increased the combinatorial potential of lineage tracing. Using
techniques like “confetti” labelling, four clones are now commonly traced in most laboratories. Other
approaches have successfully traced a hundred clones (“Brainbow”). These status quo approaches have
remained unchanged for over a decade and still fall significantly short of the thousands of colors needed for
quantitatively mapping tumor heterogeneity. This proposal provides a solution in the form of a massively
combinatorial lineage tracing strategy in mice, termed “MousePaint”. This high-risk and high-reward IMAT
project is based upon decades of genetic research from a team with an established track-record in
combinatorial lineage tracing and hyperspectral imaging. MousePaint utilizes fluorescent proteins spanning
the entire visible spectrum. Downstream hyperspectral imaging is used to image thousands of lineages and
theoretically approach True Color imaging of >1 million colors. The objective of this proposal is to perform
feasibility studies on a “MousePaint” technology that can be used to paint and visualize thousands of tumor
clones during the natural history of a cancer – including initiation, growth, and metastasis. Two Aims are
proposed. (Aim 1) To optimize a MousePaint strategy for combinatorial imaging in vivo and (Aim
2) To engineer and test a genetically encodable MousePaint for quantitatively visualizing the
evolution of intratumor heterogeneity. Completing these aims will deliver MousePaints for imaging
tumor cell heterogeneity. Hyperspectral imaging and big data analysis will benchmark MousePaint lineage
tracing and color-depth. Co-registry of MousePaint with in situ transcriptomics, molecular pathology,
histopathology, and scRNAseq compatibilities will be directly tested. MousePaint is expected to transform
cancer research by providing a simple mouse tool for True Color imaging tumor evolution at least 100 to 1000
times the resolution of available methods.

Public health relevance
PROJECT NARRATIVE Millions of dollars are being expended to build single-cell maps of the cellular, genetic, and proteomic heterogeneity in human cancers. Easy-to-use and off-the-shelf models for visualizing extreme heterogeneity in genetically tractable systems will be necessary for translating the human cancer atlas into biological mechanisms of cancer progression and therapeutic resistance. This proposal is relevant to public health because it will provide first-of-kind technology, termed “MousePaint”, for visualizing massive tissue heterogeneity and experimentally mapping cancer evolution in genetically tractable animal models.